Deep Phenotyping of 3D Data for Candidate Gene Selection from Kids First Studies

Abstract/Project Summary This project will pilot a process to explore the role of genes contributing to abnormal asymmetry in developmental disorders by combining knowledge of genotype/phenotype interactions derived from the Common Fund Knockout Mouse Phenotyping Program (KOMP2) and the Genotype-Tissue Expression (GTEx) project with family cohort data from two Gabriella Miller Kids First Pediatric Research Projects (KF): Genomic Studies of Orofacial Cleft Birth Defects and Genomics of Orofacial Cleft Birth Defects in Latin American Families. Asymmetry is a key feature of numerous developmental disorders including major structural birth defects as well as neurological disorders. A better understanding of the genetic basis of asymmetry and its relationship to disease susceptibility will help unravel the complex genetic and environmental factors and their interactions that increase risk in a wide range of developmental disorders. The KOMP2 project aims to provide comprehensive mouse knockout phenotype data, including 3D fetal imaging of sub-viable and lethal lines that are likely to play a significant role in development. In this project, automated, dense quantification of asymmetry of 3D embryonic microCT images will be used to build statistical models of asymmetry in normal development. Knockout strains will be screened for phenotypes with asymmetric structures or organs with the goal of detecting genes associated with abnormally heightened asymmetry. The functional significance of the selected genes will be validated by comparing regions impacted in knockout strain phenotypes from the KOMP2 dataset to tissue expression data from the GTEx project. Candidate genes identified using biological information from the KOMP2 and GTEx datasets will be explored f or association with the KF whole genome sequencing data from OFC parent-case trios with the aim of identifying genetic variants that are enriched in these groups compared to a control population. Identification of these variants will help shed light on the mechanisms linking congenital asymmetry and OFC risk. The outcomes of this study will include (1) statistical models of normal anatomy and asymmetry from the KOMP2 fetal 3D imaging data, (2) an open -source software to produce detailed phenotype descriptions from dense morphometric analysis of 3D images from the KOMP2 dataset, (3) correlations between phenotype descriptions from the KOMP2 knockout strains and tissue expression data from the GTEx project, and (4) analysis of the contribution of rare variants on candidate genes towards OFC risk.

Public health relevance
PROJECT NARRATIVE We study the relationship between the asymmetry and the susceptibility to developmental disorders in a model organism (mouse) using quantitative analysis. We translate the model organism results to humans using bioinformatics approaches.